Neuroinformatics for gene expression: networks, function and meta-analysis

DESCRIPTION (provided by applicant): An enduring challenge in biomedical research is deciphering the function of genes, and in particular how they work together to influence human health and disease. This project centers on the development and application of computational databases, tools and techniques for the study of large quantities of functional genomics data with a focus on the nervous system, building on our experience in meta-analysis of gene expression profiling data. Our first aim focuses on refining and applying methods for computational analysis of gene function in the nervous system, based on gene networks derived from expression profiling and other public data. Our second aim is to study the relationships between phenotypes and gene expression patterns, and applying the approaches to expression changes associated with diseases of the nervous system. Third, we propose to develop new visualization methods for gene networks, and to incorporate data on transcriptional gene regulation including transcription factor binding sites and genetic variation in gene expression. These resources will be designed to interoperate with other neuroinformatics databases, and disseminated through our Gemma web-based database system.

Public health relevance
Disorders of the brain such as schizophrenia, autism spectrum disorder, Alzheimer's disease and stroke take a huge toll on society. Improving our understanding of how genes and gene networks contribute to normal and pathological processes in the brain will contribute to the development of improved diagnostics and treatments. This project will advance such understanding in multiple ways, by developing and applying computational analyses of huge quantities of genomics data on the brain.